Role of clearance of toxic metabolites in mitochondrial and tau pathology

Summary
Mitochondrial dysfunction and synaptic damage are early pathological features of the AD-affected
brain. The underlying mechanisms and strategies to rescue such injury remain elusive. There is
limited mechanistic study investigating the likely interplays between mitochondrial dysfunction
and neuroinflammation and their contribution to synaptic damage and tauopathy in AD and related
disorder (ADRD). Age-related accumulation of toxic metabolites such as advanced glycation end
products (AGEs) and methylglyoxal (MG) perturbs mitochondrial and synaptic dysfunction. Thus,
clearance of these toxic metabolites are important for maintaining mitochondrial integrity.
Glyoxalase 1 (GLO1) is a key enzyme for scavenging/detoxifying toxic metabolite MG to reduce
AGEs formation. So far,
the role of GLO1 on tau-mediated mitochondrial stress, tau pathology,
neurotoxic oligomer tau metabolism, neuroinflammation, synaptic and cognitive dysfunction in AD
and ADRD remains unexplored.
It is unclear whether circulating AGEs metabolites correlate to
synaptic mitochondrial function and glycation, whether neuronal GLO1 is a mechanistic linker
between mitochondrial dysfunction and neuroinflammation and synaptic injury and if gaining of
neuronal GLO1 could alleviate tau pathology and synaptic and cognitive dysfunction and slow
down disease progression in AD. We hypothesize that sustained accumulation of toxic
metabolites (MG/AGEs) serves as causative endogenous danger signals to initiate and accelerate
mitochondrial perturbation and tau pathology, leading to neuroinflammation and synaptic failure.
Clearance of AGEs metabolites by GLO1 may be important for reducing the pathophysiological
modifications associated with age-related carbonyl stress and mitochondrial pathology. This
proposal will address the fundamental unexplored questions of whether GLO1 is a key player in
tau-induced synaptic injury, tau pathology, and neuroinflammation, whether augmentation of
GLO1 proves beneficial for clearance of tau and toxic metabolites, mitochondrial quality, and
cognitive function as a therapeutic strategy in AD and ADRD, whether circulating serum and
platelet AGEs-related metabolites associate with cerebral mitochondrial dysfunction, and whether
these toxic metabolites can serve as risk factors/biomarkers for the onset and/or progression of
early AD and age-related cognitive dysfunction.

Public health relevance
Narrative This proposal will address the fundamental unexplored questions of whether glyoxalase 1(GLO1) is a key player in tau-induced synaptic injury, tau pathology, and neuroinflammation, whether augmentation of GLO1 proves beneficial for clearance of tau and toxic metabolites, mitochondrial quality, and cognitive function as a therapeutic strategy in AD and ADRD, whether circulating serum and platelet AGEs-related metabolites associate with cerebral mitochondrial dysfunction, and whether these toxic metabolites can serve as risk factors/biomarkers for the onset and/or progression of early AD and age-related cognitive dysfunction.